Pragmatic Obstructive Sleep Apnea Weight Loss Trial Assessing Effectiveness and Reach (POWER)

Background: Prevalent obesity related conditions like obstructive sleep apnea (OSA) represent an important
opportunity for the VA to improve population health. OSA markedly reduces quality of life and is associated
with 3-fold greater risk for cardiovascular disease. Although obesity is the single greatest reversible risk factor
for OSA, the 1 million Veterans with OSA and obesity rarely receive weight loss care to reverse OSA and other
serious comorbidities. Efficacy trials reinforce that time and resource intensive lifestyle-based weight loss
programs improve weight and physiologic measures of OSA severity (apnea hypopnea index, AHI). However,
there are barriers to translating these findings into meaningful gains for population health. First, VA has limited
capacity to counsel patients around lifestyle change. Less than one-third of Veterans with OSA and obesity are
counseled about weight loss and even fewer are referred to weight loss services. Second, VA’s current weight
loss offerings are difficult to access. Only 12% of Veterans with OSA and obesity utilize MOVE!, and those
referred to MOVE! achieve minimal weight loss—1.2 kg at 1 year. Third, prior weight loss trials focused on
intermediate measures (e.g. AHI), limiting understanding of effectiveness for meaningful outcomes. To meet
these challenges, we propose a pragmatic trial of proactively offering a remote video-based and self-directed
weight loss intervention with telephone-based coaching to Veterans with newly diagnosed OSA. Our weight
loss intervention (D-ELITE) is adapted from a program known to be effective in a non-VA population, with 44%
of participants achieving ≥5% weight loss at 24 months. Further optimizing reach, our remote intervention
includes low-technology options (e.g. DVD videos) to accommodate those with low technology literacy.
Significance: Our research tests a program of proactively providing Veterans with OSA the tools to manage
weight loss in a way that is independent of local provider time and resources. Our research addresses a key
gap in Veteran’s health in a way that aligns with important VA priorities including population health, virtual care,
access, and health care value. We anticipate our intervention can efficiently achieve improvements in quality of
life while reducing the burden and risk of serious comorbidities.
Innovation and Impact: Our research directly challenges the traditional provider-driven model of healthcare
delivery where providers direct care and provide necessary services aimed at managing a single disease.
Instead, we propose to proactively deliver weight loss services to a high-risk group using a population health
approach. In doing so, we will conduct the first trial of remote and self-directed weight loss care in OSA and will
test whether weight loss care can improve meaningful outcomes such as quality of life and cardiovascular risk.
Specific Aims: Our primary aim is to test the effectiveness of a proactively delivered and pragmatic weight
loss intervention to improve co-primary endpoints of sleep-related quality of life and weight among Veterans
with OSA and obesity. Secondarily, we will compare additional outcomes between groups: cardiovascular risk
scores, sleep symptoms, and AHI. Finally, we will also conduct an implementation process evaluation informed
by the RE-AIM framework to identify barriers and facilitators to widespread implementation.
Methodology: We plan a hybrid type 1 pragmatic randomized controlled trial. We will proactively identify
Veterans with OSA and obesity nationwide using data from the CDW (n=696), randomizing 1:1 to usual care
plus the D-ELITE weight loss intervention or usual care alone. We will collect primary outcomes at 12 months,
but we will also collect outcomes at 3 and 24 months to assess trends over time. We will use quantitative and
qualitative methods to assess barriers to implementation, including a comprehensive budget impact analysis.
Next Steps/Implementation: If effective, we will work with our operational partner, the National Center for
Health Promotion and Prevention (NCP), to integrate D-ELITE into NCPs suite of weight loss offerings. The
National Program Office for Pulmonary/Sleep also agrees to promote policies supporting nationwide adoption.

Public health relevance
Obstructive sleep apnea (OSA) is an obesity-related condition that affects 1.3 million Veterans, reduces quality of life, and is associated with greater risk of cardiovascular disease. Despite the potential of weight loss to reverse OSA, real-world impact is limited. Veterans seldom receive weight loss services due to a lack of counseling and poor accessibility of current weight loss offerings. Furthermore, there is uncertainty around the benefits of modest weight loss in achieving meaningful outcomes in OSA. To overcome access and knowledge gaps, this trial will examine the effectiveness of a population health approach to weight loss care among Veterans with OSA. We will use a remote lifestyle-based weight loss intervention that is self-directed, low- technology, and likely low cost. We propose a pragmatic trial of proactively delivering this novel intervention among patients with newly diagnosed OSA. We will test whether such an intervention improves weight and meaningful outcomes including sleep-related quality of life, sleep symptoms, and cardiovascular risk.